Defining choline metabolism in metabolic health

Project Summary
The impairment in choline catabolism to its methyl-donor, betaine, is strongly related to the development of
metabolic-associated liver disfunction (MASLD). In order for choline to be metabolized, it must be transported
into the mitochondrial matrix. However, limitations in the understanding subcellular localization of choline have
limited the understanding of choline metabolism in the development of MASLD. My work has identified
SLC25A48 as a mitochondrial choline carrier (MChoC, SLC25A48) which regulates choline subcellular
localization and metabolism. Elucidating the regulation choline metabolism under obese conditions may reveal
novel mechanisms of treating MASLD. This proposal tests the hypothesis that diet induced obesity disrupts
choline contribution to the methionine cycle which regulates metabolic health. A first set of studies focuses on
the regulation of choline flux in the liver. I will map the fate of choline in the livers of control and MChoC liver-
specific knockout (MChoC-LKO) mice through in vivo flux analysis with stable-labeled choline coupled with
LC/MS. I will also determine whether overexpression of MChoC in livers of obese mice is sufficient to rescue
fatty liver disease. A second set of studies will focus on choline dependent changes in epigenetics. This set of
studies will expand my technical training with support from co-mentor Dr. Evan Rosen. To address the epigenetic
modifications dependent on choline metabolism we will assess chromatin architecture regulated through histone
methylation and translational control through polysome profiling in MChoC-LKO mice. A third set of studies will
test the regulation of obesity on the choline metabolic pathway through proximal-labeling and in vivo complex
assessment. Completion of these studies will expand the scope of my work, provide foundational datasets, and
establish models that will be essential toward achieving my career goal of leading and developing scientists as
an independent investigator.

Public health relevance
Project Narrative Disrupted choline metabolism is strongly associated with type 2 diabetes and metabolic dysfunction-associated liver disease (MASLD). I have recently identified the mitochondrial choline carrier which regulates the subcellular location and metabolism of choline. With models targeting the mitochondrial choline carrier, this proposal will identify whether obesity disrupts choline contribution to the methionine cycle with the goal of identifying new targets to treat metabolic disease.